Targeting the Notch:Myc axis in leukemia/lymphoma

Project Summary
Activating Notch mutations are found in both human T cell acute lymphoblastic leukemia cases (T-ALL) and B
cell leukemias/lymphomas including Mantle Cell Lymphoma (MCL). A direct transcriptional target of Notch in
both malignancies is the proto-oncogene Myc, which is the most frequently amplified oncogene across a wide
range of malignancies as it has critical roles in gene transcription, metabolism, cell proliferation and survival. In
the proposed work, we will characterize Myc transcriptional regulation in both T-ALL and MCL. We previously
identified a distal (1.3 Mb 3' to the promoter) T cell specific Myc enhancer region termed the Notch-Dependent
Myc Enhancer (NDME), that is active in a reporter assay and loops to the Myc promoter in mouse and human
T-ALL cells. At least four T cell transcription factors bind in this region, however, their role in activating the
NDME is unknown. Previous work from our lab showed that T-ALL cells created to be resistant to Notch
inhibition maintain Myc expression through a switch in enhancer usage to another region, termed the Brd4-
Dependent Myc Enhancer (BDME). A potential treatment for T-ALL is the BET family inhibitor JQ1, which has
already proved efficacious in AML. We generated JQ1-resistant human T-ALL cells that maintain MYC
expression. Unlike the T cell NDME, the B cell NDME is located ~500 kb 5' to the Myc promoter and
surrounded by B cell specific transcription factors. The goal of this proposal is to understand Notch-dependent
Myc regulation in both T-ALL and MCL. In particular, we will determine how Notch regulates Myc enhancer
states in T-ALL and MCL and identify factors that cooperate with Notch to “set-up” and maintain the T cell and
B cell NDMEs. In addition to elucidating the function of these enhancers, we will determine how Myc enhancer
states dictate drug sensitivity and resistance in T-ALL cells. Together, This work will provide critical insights
into the mechanisms of Myc regulation in leukemia and lymphoma and may identify novel targets for treating
both de novo and refractory T-ALL and MCL.
!

Public health relevance
Project Narrative Myc is an important oncogene hematopoietic malignancies due to its central role in regulating transcription, metabolism, proliferation, and survival. My research will provide key insights into how oncogenic Notch signaling dysregulates Myc in leukemia and lymphoma and identify novel therapeutic targets in this disease.